Developmental Psychopathology

Project Summary
The purpose of the proposed program is to train the next generation of scholars in developmental
psychopathology who will conduct multiple levels of analysis research addressing one or more of
NIMH’s 2020 strategic objectives. The proposal requests continuation of a training program at the
Institute of Child Development, University of Minnesota, continuously supported by the National
Institute of Mental Health since 1959. In 1981 this training program added postdoctoral students
and now consists of 3 predoctoral and 2 postdoctoral position. In this application, based on the
growth of our faculty and the increase in BIPOC and other URM students, we are requesting 4
rather than 3 predoctoral positions. The award-winning faculty on the training grant reflect various
sub- disciplines of developmental science, including child clinical psychology, developmental
behavioral neuroscience/developmental psychobiology, stress neurobiology, socioemotional
development, cognitive development, pediatrics, and prevention/intervention science. External
training faculty from other departments across the University of Minnesota (e.g., Family Social
Science, Pediatrics, Psychiatry, Psychology, Pharmacology, Public Health - see Table2 in
application) also will serve as co-mentors of the pre- and –post doctoral trainees. This allows our
trainees to take advantage of the full richness of research in developmental psychopathology
available at the Universityof Minnesota. In any given year, the predoctoral trainees represent
approximately 10% of all Ph.D. students in the Institute of Child Development; thus, being placed
on the training grant is highly competitive. Students enter the training grant as 2nd, 3rd or 4th year
Ph.D. students (preferentially 3rd or 4th year) so that we can be more confident of their talent and of
their commitment to research areas pertinent to NIMH’s strategic goals. Postdoctoral trainees are
selected based on evidence of research potential, strong recommendations, and fit with the
program. Predoctoral trainees complete one of two Ph.D. tracks, the Developmental Science track
or the Developmental Psychopathology Clinical Science track; the latter involves a one-year
clinical internship. All predoctoral trainees receive training in professional development, ethics in
research, statistics, and cognitive and social development as part of the larger Ph.D. program. T32
trainees in addition take a course in developmental psychopathology, attend the annual research
ethnic UMN conference, present at the annual clinical research day and complete a grant-writing
course. Postdoctoral students complete the grant writing course and, in consultation with their
faculty mentor and the training grant director, any areas of developmentalscience that are critical
to their research program and in which they lacked sufficient prior training.

Public health relevance
Project Narrative The purpose of the proposed program is to continue a training program at the Institute of Child Development (ICD) that has been supported by NIMH since 1959 and that in 1981 added postdoctoral trainees. Its goal is to train the next generation of scholars in developmental psychopathology who will conduct multiple levels of analysis and interdisciplinary research addressing of NIMH’s strategic objectives. Consistent with the fourth strategic objective, our trainees gain experience in community engagement and translation of research findings to practical application.